The Role of Cryptochromes in environmental regulation of growth

ABSTRACT
A fundamental question in biology that has yet to be answered is how an organism's environment regulates its
growth and development. Unlike animals, plants neither have specific organs that see or hear various
environmental stimuli nor can they move around to avoid adverse conditions. Although lacking a brain, plants
can successfully integrate internal and external cues and make appropriate decisions about growth. In contrast
to animals, growth in plants occurs post-embryonically, to produce new organs and for the growth and
modification of existing forms to adapt to the local environment. Light is among the most relevant environmental
signals because it not only drives photosynthesis but also provides critical information about the local growth
environment as well as diurnal and seasonal timing. Over the next few years, my laboratory will aim to understand
the molecular mechanisms by which a plant perceives and responds to its light environment. To address our
questions, we will use cryptochromes (CRYs), the UV-A/blue light photoreceptors, as they form the interface
between the light environment and the organism. CRYs are present in diverse organisms, including humans,
where they regulate circadian rhythms and several physiological processes, like metabolism, growth, and
magnetoreception. We will obtain mechanistic insights on how CRY regulates gene expression at the cellular
level, which leads to morphological changes at the organismal level. We will also determine how light and the
newly identified CRY2-associated molecules that we have discovered function in CRY-mediated signaling
pathways. Also, our research will unravel the novel mechanisms by which CRYs, through their interaction with
the RNA-binding proteins that we have discovered, control RNA metabolism, specifically that of methylated
RNAs (m6A). m6A is an RNA modification that controls its fate as a reversible regulatory mark, and disruption of
RNA methylation leads to growth defects in plants and is linked to several human diseases. We will also address
how CRYs integrate environmental signals and modify chromatin through their interaction with chromatin
remodelers, whose findings will fill a large void in this field. The success of this study will significantly improve
crop productivity to feed the growing human population and aid in the development of optogenetic tools to target
neuronal disorders. In humans, disruption of CRY activity is associated with many human disorders, including
cancer, inflammation, insomnia, and diabetes. Understanding CRY function can lead to both prevention and
treatment of these diseases. Taken together, our research will have a broad impact on agriculture and human
health and disease.

Public health relevance
PROJECT NARRATIVE Cryptochrome (CRY) UV-A/blue light photoreceptors are found in humans and plants, where they regulate diverse processes like circadian rhythms, tumor suppression, metabolism, DNA repair, flowering, and growth. The proposed studies aim to determine the molecular mechanisms by which CRYs interpret light quality and quantity to regulate plant growth. Understanding the mechanisms of CRY and its associated signaling will lead to improved crop yields for human nutrition and the prevention and development of therapies for diseases linked to impaired CRY function like cancer, diabetes, and neuronal disorders.